Genetically Programmed Pancreatic Organoids with Self-Adaptive Multi-Lineage Population Control

Major advancements in stem cell biology have paved the way for innovation in organoid engineering. Organoids
are 3D tissues derived from human induced pluripotent stem cells (hiPSCs) generated by reprogramming patient-
speciﬁc adult cells, such as ﬁbroblasts. While organoids show great promise as testbeds for investigating devel-
opmental biology, current methods for organoid production are limited by their reliance on external inputs, such
as growth factors and small molecules, which affect cells imprecisely and give rise to immature organoids that do
not faithfully recapitulate in vivo physiology and functionality. The resulting organoids are size-constrained, lim-
ited to a small set of cell types, and do not generally develop mature tissue that exhibits the functionality of fully
developed organs. While we have previously demonstrated genetic programs that enable organoids to generate
all requisite cell types in liver, variability in cell ratios remains an open challenge for achieving reproducible, high
quality organoids. Further, progress is blocked by the inability to reliably guide multi-lineage speciﬁcation, the lack
of precise timing of multistep differentiation, and the inability to make robust bifurcation decisions that determine
the ratios of the resulting cell types.
To overcome these obstacles, we will combine synthetic biology, developmental biology, and control theory to
design novel open and closed loop genetic controllers that individually guide differentiation from within each cell
to form unique new 3D tissue: vascularized pancreatic organoids with deﬁned ratios of endocrine and exocrine
cells. We will demonstrate how these new organoids can serve as more sophisticated and comprehensive models
for investigating developmental biology principles. This work will spearhead a transformation in organoid synthesis
by shifting the ﬁeld from manual addition of inductive chemical signals to cell type conditional, self-timed ectopic
expression of transcription factors that induce differentiation. Building upon the premise that 1) gene sensors can
detect cell types speciﬁc to differentiation stages, and 2) at least in certain important cases, regulated expression
of lineage-specifying transcription factors can guide differentiation to the next stage, our main hypothesis is that
feedback regulation of cell lineage bifurcation decisions can lead to more robust and reproducible sub-population
ratios in organoids in comparison to open loop approaches. Our organoids will contain synthetic developmental
programs that are self-timed and globally-orchestrated, with cells working together to generate the requisite ratios.
We will create a platform for programmed bifurcation decisions that can be used for other differentiation steps
in the pancreas, and more broadly to other organoid and tissue types. We will use this platform to perform
novel developmental studies to systematically vary the ratio of endocrine to exocrine cells and measure the
consequences on exocrine/endocrine cells and their differentiation and function. The ability to precisely vary the
ratio while studying gene expression proﬁles, the organoid secretome, and its affects on target cells will provide
invaluable beneﬁt in the investigation of pancreas development and dysfunction.

Public health relevance
We will apply synthetic biology and advanced control theory techniques to genetically program human induced pluripotent stem cells (hiPSCs) that generate vascularized pancreatic organoids suitable for endocrine/exocrine and other developmental studies. Our engineered genetic circuits embedded in hiPSCs will regulate multi-step differentiation of these hiPSCs into desired population ratios of the multiple lineages comprising complex pancreatic organoid structures. Our proposed research represents a departure from current in vitro organoid synthesis protocols and will usher in a fresh perspective on organogenesis that will be germane to the precise synthesis of any organoid, as well as to other feedback regulated multi-cellular systems.